MIEDZYNARODOWY INSTYTUT ONKOLOGII MOLEKULARNEJ:1268477 [16-013238]Tissue Source Site (TSS) Clinical Proteomics Tumor Analysis Consortium (CPTAC)This modification is to add and exercise an option f

The National Cancer Institute’s Clinical Proteomic Tumor Analysis Consortium (CPTAC) is a national effort to accelerate the understanding of the molecular basis of cancer through the application of large-scale proteome and genome analysis, or proteogenomics. Launched in 2011, CPTAC pioneered the integrated proteogenomic analysis of colorectal, breast and ovarian cancer to reveal new insights into these cancer types, such as identification of proteomic-centric subtypes, prioritization of driver mutations by correlative analysis of copy number alterations and protein abundance, and understanding cancer-relevant pathways through posttranslational modifications. CPTAC is currently leveraging its investment in cancer proteogenomics by characterizing additional cancer types, expanding its application through open-source community resources, and accelerating precision oncology by applying proteogenomics to questions of toxicity and resistance in clinical trials. This is being achieved through a coordinated effort by CPTAC-affiliated Proteome Characterization Centers, Proteogenomic Translational Research Centers, and Proteogenomic Data Analysis Centers located throughout the country. IIMO will collect surgically resected biospecimens for use in the CPTAC project.